ATOVAQUONE VS LOW DOSE ATOVAQUONE VS AEROSOLIZED PENTAMIDINE IN HIV INFECTION

The purpose of the study is to compare the safety and efficacy of two doses of atovaquone and aerosolized pentamidine in the prevention of Pneumocystis carinii pneumonia (PCP) in HIV-infected patients who are at high risk to PCP and who are intolerant of trimethoprim/sulfamethoxizole or other sulfa-containing regimens.